A Mixed Methods Assessment of Clinic Characteristics Associated with Successful Scale-up & Sustainment of Systems Navigation & Psychosocial Counseling for People Who Inject Drugs with HIV in Vietnam

ABSTRACT
Globally and in Vietnam, people who inject drugs (PWID) are disproportionately impacted by the HIV epidemic.
PWID have considerably lower levels of care engagement and experience worse HIV outcomes than
individuals with HIV who do not inject drugs. Efforts to scale-up HIV testing and treatment have largely failed to
reach PWID, who experience unique barriers to care. Even fewer of these evidence-based interventions (EBIs)
have been normalized (the process by which an intervention is integrated into routine clinic care) and
sustained, resulting in significant losses of time and resources. The success of EBI implementation and
sustainment is affected by clinic characteristics, which can act as important implementation barriers or
facilitators. However, the ways in which clinic characteristics are related to EBI fit, normalization, and
sustainment are poorly understood. The proposed fellowship builds on the applicant’s prior background to
prepare her for a career as an independent mixed methods researcher and implementation scientist. The
specific fellowship goals are for the applicant to 1) develop a strong foundation in conducting HIV-related
implementation science research; 2) build advanced quantitative analysis skills in analyzing and interpreting
statistical models; 3) expand her expertise in conducting mixed methods research and analysis; and 4) deepen
her skills in presenting research findings and grantsmanship. These goals will be accomplished through
coursework, mentorship from the sponsor and mentorship team, and execution of the proposed research
project. The proposed mixed methods research will be completed within the context of a larger NIDA-funded
cluster randomized implementation trial with 42 HIV testing sites in 10 provinces in Vietnam (Scaling up HPTN
074: a Cluster Randomized Implementation Trial of an EBI for Antiretroviral Therapy for PWID in Vietnam,
5R01DA047876-02). This study will identify key clinic characteristics for scale-up and sustainment of the
systems navigation and psychosocial counseling (SNaP) EBI in Vietnam, and examine how adaptations to
both the intervention and implementation strategies influence sustainment of SNaP. Aim 1 will use qualitative
interviews conducted with participant PWID (n=36) and clinic staff (n=24-36), survey data collected at baseline
and endline, and the modified Delphi method (to improve scale-up measurement) with US and Vietnamese
experts in HIV and implementation science to identify factors influencing clinic scale-up success of SNaP. Aim
2 will use clinic staff surveys across the 42 sites to evaluate sustainment of SNaP and clinic-level factors
associated with sustainment. Aim 3 will involve 24-36 qualitative interviews with clinic staff and directors to
determine how intervention and implementation strategy adaptations and clinic characteristics influence SNaP
normalization and sustainment. The proposed research aligns with NIDA’s goals of bridging the research-to-
practice gap by providing evidence-informed guidance to Ministries of Health in Vietnam for optimizing scale-
up and sustainment of SNaP, which has the potential to increase wellbeing for PWID with HIV globally.

Public health relevance
PROJECT NARRATIVE The HIV epidemic in many global settings is highly concentrated among people who inject drugs (PWID), and efforts to scale up HIV treatment have largely failed to reach this population. The proposed research utilizes a mixed methods, implementation science-focused approach to explore the understudied relationship between clinic characteristics (which can act as significant barriers or facilitators to intervention implementation) and the scale-up, adaptation, and sustainment of an evidence-based systems navigation and psychosocial counseling intervention for PWID with HIV in Vietnam. Findings can inform governments globally on how to distribute limited resources, based on clinic characteristics, to scale up and sustain effective HIV interventions for PWID, ultimately reducing mortality and improving wellbeing for PWID with HIV across low and middle-income countries.